Analytical approaches to fatty acid oxygenases and their lipid mediator products

Analytical approaches to fatty acid oxygenases and their lipid mediator products
Project Summary/Abstract
This program focuses on technically challenging questions related to lipoxygenases, their associated enzymes
and proteins, and an unprecedented higher-resolution analysis of mechanisms of biosynthesis and fate of the
oxidation products. These pathways are conserved widely in evolution and ubiquitous in higher animals. A major
thrust is uncovering the mechanistic basis of how a 12R-lipoxygenase (12R-LOX) metabolic pathway functions
to secure formation of the water permeability barrier in the epidermis. Pathway genetic deficiencies have
devastating consequences, being neonatal lethal in mice and in humans causing congenital ichthyosis (scaly
skin), an extremely socially challenging condition. We identified 12R-LOX, epidermal-LOX-3, and the
dehydrogenase SDR9C7, as working in series to oxidize linoleic acid (18:2w6) that is esterified in a skin-specific
acylceramide. Such oxidations are essential for covalent binding of ceramides to barrier protein, forming sub-
structures visible by EM: the corneocyte lipid envelopes. We will apply a singular combination of technical
resources (recombinant enzymes and barrier proteins, novel LOX products, unique collection of oxidize
acylceramides, access to mouse knockout epidermis, quantitative LC-MS assays, proteomics) to uncover how
12R-LOX oxidations lead to sealing the permeability barrier. Our hypothesis rides on the nature of the linoleate-
ester oxidation, which forms an epoxy-enone-linoleate, reactive with nucleophiles and capable of adducting to
protein. Understanding these mechanisms will have long-term impact on treatment of skin barrier-related
diseases as well as optimizing artificial skin production for treating burns and severe diabetic ulcers. In a second
arm of the program, we address technical questions in the field of lipoxygenase product biosynthesis. First,
defining the biochemical mechanisms of forming the oxygenated derivatives of “fish oil” fatty acid EPA and DHA,
products currently cited as pro-resolving in inflammation, the biosynthesis remaining controversial over the past
20 years. Second, the mechanisms in cyclization of fatty acid allene oxides (highly unstable epoxides) to
cyclopentenones. The latter is relevant to heme-protein chemistry and to synthetic chemistry of cyclopentenones
and other 5-membered carbocycles. Summing up the vision and suitability for the freedom afforded by MIRA
funding: we address mechanistically important and challenging projects, apply unparalleled technical abilities
including analysis of extremely unstable pathway intermediates, and leadership in exemplifying the highest
standards in the fields of lipoxygenases and related lipid oxygenases.

Public health relevance
Project narrative-relevance statement Lipids are a source of important signaling molecules that regulate health and disease in the body. Our research is focused on how lipid oxidizing enzymes called lipoxygenases produce novel lipid signals and how these act in the body. An understanding of the role of these lipid metabolizing enzymes and of the lipid oxidation products will ultimately lead to more rational treatments of a spectrum of conditions including inflammation and skin diseases.